Out-of-pocket spending and burdensome care for older adults with serious illness

PROJECT SUMMARY/ABSTRACT
Over 40 million people in the U.S. live with serious illness, many of whom experience significant
financial impact due to the high costs, utilization, and risk of mortality that accompany serious illness. Older
adults in particular have a greater number of chronic conditions and lower income to manage increased health
spending as they retire. One quarter of older adults experience out-of-pocket spending (OOPS) in the last five
years of life that exceeds their entire household assets. Despite the disproportionate impact of high OOPS on
older adults with serious illness, the underlying drivers of high OOPS, and the potential care consequences
from high OOPS for this population, are inadequately understood.
Prior studies show drivers of higher OOPS for seriously ill older adults include serious illness type,
health care utilization, insurance type, and living situation, among other factors. However, none have examined
how insurance generosity affects high OOPS for seriously ill older adults. Insurance generosity varies within
insurance types and can be dictated by state-level policy. Omitting insurance generosity from models of high
OOPS excludes a highly modifiable factor that could mitigate high OOPS and their consequences.
Such consequences of high OOPS include potentially burdensome care (e.g., emergency department
reliance, days away from home, care transitions in the last three days of life, and in-hospital death), some of
which have been associated with lower care quality at end-of-life as rated by patients and families; and
depression, which has a well-established relationship with decreased wealth. Examining insurance generosity
at the onset of serious illness, when OOPS is typically most concentrated, may further illuminate a path
through which potentially burdensome care, depression, and care quality could be addressed.
In this project, we will leverage rich health and financial data from the nationally representative Health
and Retirement Study (HRS) to a) determine the relative contributions of insurance generosity, serious illness
type, and other factors to high OOPS among Medicare beneficiaries over 65 with new-onset serious illness,
and b) test the association of insurance generosity during serious illness onset with subsequent burdensome
care and depression among Medicare beneficiaries over 65. Such analyses will provide a more complete
picture of the factors contributing to high OOPS for a population that is most affected, and also reveal novel
insights on the relationship of insurance generosity with burdensome care and depression. These data can
guide researchers, health systems, policy makers, and the public towards consideration of insurance
generosity as a possible target for intervention. Mitigating high OOPS and its consequences at serious illness
onset has the potential to interrupt a cascade of wealth depletion, worsened depression, health decline, and
escalating care needs for older adults with serious illness.

Public health relevance
PROJECT NARRATIVE Out-of-pocket spending (OOPS) is typically concentrated in the first year of serious illness and may be associated with subsequent burdensome care, which has been linked with lower care quality at end-of-life; and subsequent worsened depression, which has a well-established relationship with decreased wealth. This project will a) test the relative drivers of high OOPS, including insurance generosity which has not been previously examined, and b) whether high out-of-pocket spending (OOPS) during the onset of serious illness results in higher risk of subsequent burdensome care and depression for Medicare beneficiaries over 65. These data can guide researchers, health systems, policy makers, and the public towards possible targets for intervention to reduce high OOPS experienced at serious illness onset, and potentially interrupt a cascade of wealth depletion, worsened depression, health decline, and escalating care needs for older adults with serious illness.